Mitochondrial Gene Editing in Human Cardiomyocytes

Mitochondria (mt) are regarded as critical components for cardiomyocyte homeostasis and are the nexus of
many signaling events that maintain normal cardiac function. As a result, mutations in mitochondrial DNA
(mtDNA) have been shown to affect cardiac myocyte function and are associated with the development of
cardiomyopathy in ~25% of all mtDNA mutation carriers. However, it is difficult to define mtDNA mutations as
the cause of a particular pathology because the penetrance of mtDNA disease is not mendelian and is dependent
on the amount of heteroplasmy of mtDNA mutations per cell, the cell type expressing mutations, as well as the
specific mutation. Some canonical mtDNA mutations, in particular mt-tRNA mutations, have been shown to be
displayed at higher heteroplasmic states and are defined as causative sources for cardiomyopathy, such as in
mitochondrial myopathy, encephalopathy, lactic acidosis and stroke-like episodes (MELAS) syndrome caused
by a mt-tRNALeu mutation (m.3243A>G). Many mtDNA diseases, such as MELAS, present with aging, yet it’s not
completely defined why and how different cardiomyocytes or other cardiac cells i.e., endothelial or fibroblasts,
are affected by the presence of MELAS mutations. Understanding of the mechanism of cardiomyopathy by
mtDNA mutations would be advanced by useful mtDNA gene editing strategies. In this proposed research plan,
we present a novel Cas9 based mitochondrial gene editor system (mEditors) that we designed to introduce
mtDNA mutations into human IPSC cardiomyocytes (IPSC-CMs), with the ultimate goal to ascribing pathogenic
and potentially causal relationships between specific mtDNA mutations and cardiomyopathy. We hypothesize
that mEditors can be used to introduce, rescue, and regulate mtDNA heteroplasmy states of the common MELAS
mutation (m.3243A>G), allowing hypothesis-testing on the presence and level of mtDNA mutations with
functional effects on cardiomyocytes. The following aims are designed to test these hypotheses:
Aim 1: To test the hypothesis that mEditorS can be used to introduce mtDNA mutations in human
cardiomyocytes.
Aim 2: To test the hypothesis that mEditorS can remove mtDNA mutations in human
cardiomyocytes.
Aim 3: To test the hypothesis that mtDNA heteroplasmy can be regulated by mEditors in
conjunction with functional alterations in human cardiomyocytes.
This project will advance a novel mtDNA editing tool with the goal for ascribing causality for mtDNA
mutations and possible future therapeutic development for mitochondrial diseases.

Public health relevance
Mitochondria (mt) are regarded as critical components for heart muscle cells and crucial for normal cardiac function. This project uses new gene editing technology to study mitochondria in human heart muscle cells.